EFFECT OF GLUCAGON ON POSTPRANDIAL GLYCEMIA AND GASTRIC MOTILITY IN NIDDM

To evaluate the effect of glucagon on motility and gastric emptying to possibly provide information on why blood glucose control after a meal may be abnormal in diabetes mellitus.